Mechanisms of Alzheimer's Disease Progression in the Aging Brain

PROJECT SUMMARY
While late onset sporadic Alzheimer's disease (AD) is usually announced with amnesia, the aggregated
proteins β-amyloid (Aβ) and tau probably deposit in the brain for many years before symptom onset. This
process occurs in the brain's episodic memory system, on a background of normal aging. Increasing evidence
points to the spread of the tau protein out of the medial temporal lobe and into neocortical brain regions as
crucial in the transition from normal aging to AD, possibly driven by Aβ and patterns of neural activity and
connectivity. In this project we will specifically examine two subsystems of the episodic memory system, an
anterior temporal (AT) system originating in lateral entorhinal cortex (LEC) specialized for object memory, and
a posteromedial system (PM) system originating in medial entorhinal cortex (MEC) specialized for spatial
memory. This is important for differentiating aging and AD because tau deposition begins in the LEC in older
brains, while Aβ deposits in the PM system. The application builds upon on a longitudinal cohort consisting of
almost 200 cognitively normal older people who have previously had baseline amyloid PET scanning with
[11C]PIB, longitudinal structural MRI exams, and some of whom have had tau-PET imaging with
[18F]flortaucipir. For this project, 120 participants will undergo a baseline examination of PIB-PET, flortaucipir-
PET, structural MRI, and neuropsychological testing of memory and other cognitive abilities; these procedures
will be repeated 1.5 and 3 years later. The baseline examination will also include a functional MRI experiment
in which participants encode novel objects and scenes to define the AT and PM episodic memory systems.
Neural activity will be examined using directed functional connectivity (directed-FC), an analytic approach
employing Granger causality with assessment of neural activity directed from one region to another. This
directed-FC will model the spread of tau through memory systems over the ensuing 3 years. Aim 1 will
examine the overall pattern of tau spread in relation to the presence of Aβ, longitudinal cortical atrophy, and
cognitive change. We hypothesize that Aβ will speed tau spread, which in turn will be associated with atrophy
and memory decline. Aim 2 will examine tau spread through the AT and PM systems. We hypothesize that tau
spreads predominantly in the AT system and, as such, reflects an enhancement of the processes that begin in
the aged brain and not an anatomical or functional new condition. Aim 3 will use directed-FC to predict the
spread of tau over time, with the hypothesis that brain regions most strongly connected to the entorhinal cortex
will show the most rapid spread of tau pathology and this will be strongest in the AT system. How tau spreads
through these systems and how Aβ and neural connectivity may drive this spread could help to differentiate the
earliest stages of AD from normal aging, identify normal individuals at highest risk of progression, and provide
new approaches to the selection of individuals for clinical trials.

Public health relevance
PROJECT NARRATIVE This project will use a multimodality imaging approach to understand how Alzheimer's disease (AD) evolves in the aging brain. By explaining the factors involved in the spread of the protein tau in the brains of older people, we will be better able to understand how normal older individuals progress to having AD. This will improve our ability to detect AD in its earliest stages so that we can better develop methods of intervention and prevention.